Improving the clinical utility of preschool language sample analysis

Project Summary
Late talking (LT; late emergence of expressive language skill) in the absence of obvious primary
perceptual, cognitive or motor impairment, is a serious developmental condition that may lead to
academic, social and vocational handicap. While a majority of LTs appear to recover, many do not “catch
up” and predicting why outcomes differ has been elusive. This supplemental application seeks to use a
subset of the data being analyzed by the parent grant to perform a variety of longitudinal analyses of
speech and language growth in late talkers (LTs) compared with typically-developing (TD) peers. Its
overarching aim is to detect skills prior to and at roughly 24 months of age that may predict which
children recover from late onset of expressive language and which children will experience lasting
expressive language impairment. Our approach includes tracking the following sets of skills/behaviors
from 24 to ~ 60 months of age in a combined cohort of > 70 LTs (and their TD peers). Of the LT children,
roughly one-third remained persistently delayed by kindergarten entry, while 2/3 recovered to within
the TD range of achievement. We examine: 1) growth in phonological inventory and syllable structure
development; 2) recast behaviors by parents and the children’s responses to such recasts; 3) growth in
expressive vocabulary diversity using a recently re-validated measure of lexical development; 4)
differences in expressive phrase structure development, as measured by the Index of Productive Syntax,
as potential predictors of more favorable outcome from LT. We will also examine whether infant speech
segmentation and statistical learning skills assessed before 12 months of age in an additional sub-corpus
followed by the parent grant were predictive of recovery from LT. A final analysis will examine the
relationship of nonword repetition (NWR) at 24 months of age to later expressive language skills. Factors
that appear to influence outcome of LT will be incorporated into a statistical model that best captures
individual risk for persistence and recovery. Results will enable better and earlier identification of
children for whom more intensive and targeted intervention is warranted. Further, understanding which
skills appear to predict recovery will enable more informed language intervention targets and methods.

Public health relevance
Late onset of talking (LT) in toddlers is a serious health concern that may lead to serious adverse academic, social and vocational outcomes. Using archival language samples of LT children who did and did not recover and matched typically-developing (TD) peers, we model potential predictors of LT persistence. Results will enable earlier and more targeted intervention to build skills more likely to improve outcomes for LT children.